Administrative Supplement to Continue NCI-Supported Community Outreach Capacity through Community Health Educators of the National Outreach Network

Project Summary
The Knight Cancer Institute Community Health Educator program reaches our catchment area of the state of
Oregon. Oregon is a largely rural state, with 25 of our 36 counties coded as rural or “non-metropolitan” (Rural-
Urban Continuum codes (RUCC) 4-9) counties. These counties constitute a large geographic area and are
quite distant from a city center and from the OHSU Knight Cancer Institute, the only designated cancer center
between Seattle and Sacramento. The Knight Cancer Institute is committed to addressing cancer health
disparities resulting from the combined burden of racial/ethnic underrepresentation and geographic isolation
through integration of Community Health Educators within Knight Community Outreach and Engagement
(COE). Over the past two years we have focused our efforts on increasing education and uptake of HPV
vaccination and education, awareness and enrollment in cancer clinical trials, with a particular emphasis on our
highly rural and low-income communities. Despite the dramatic impacts of COVID-19 over the past year we
have had success in reaching and educating individuals who were spending more time online (we heavily
promoted HPV education to college-aged populations, gathering 69 completed pre-post surveys; our CT-101
initiative garnered 2 completed pre-post surveys and we had 3 successful trial enrollments). In the past year
we have made substantial adaptations to our approaches, allowing us to extend our reach to the entire state.
In the coming two years we will continue implementation of these successfully adapted approaches, including
the addition of mobile van education and vaccination and extension of CEUs to the statewide Traditional
Health Worker workforce. These efforts are aligned with the larger comprehensive work of the Knight
Community Outreach and Engagement program, allowing for sustained implementation of innovative,
collaborative-heavy CHE approaches.

Public health relevance
Project Narrative The Knight Cancer Institute Community Health Educator (CHE) program leverages academic and community partnerships to address cancer health disparities through outreach, education, research and access to care. Over the past two years we have focused our efforts on increasing education and uptake of HPV vaccination and education, awareness and enrollment in cancer clinical trials, with a particular emphasis on our highly rural and low-income communities. In the coming two years we will continue implementation of these successfully adapted approaches, including the addition of mobile van education and vaccination and extension of Continuing Education Units (CEUs) to the statewide Traditional Health Worker workforce.